CGH - Center for Global Health Data Analysis, Technical Support and Dialogues

The Center for Global Health (CGH) supports the NCI mission by advancing global cancer research and coordinating NCI engagement in global cancer control. CGH also represents NCI in international research partnerships, playing a key role in coordinating multinational research efforts for global benefit.
The contractor provides data support to compile, analyze, and prepare written reports on global health grant portfolios. CGH produces a variety of documents and publications each year, targeted at various audiences (most frequently Congress, advocates, scientists, NCI leadership and the American and global publics). The Contractor provides additional scientific and technical writing support for NCI-prepared documents, NCI publications, and CGH Web site content.
The contractor provides technical knowledge through expert consultancies for the work of the CGH, as relevant to CGH’s mission. The contractor supports global oncology discussions through arrangements for meetings and scientific exchange (travel of non-USG, mostly LMIC scientists) for the meetings. They provide logistical support for the documentation that is shared during the dialogues. The contractor also provides logistical support for individual training activities that involve bringing an individual trainee, who may be from the U.S. or any other country, to the site of his/her training experience either inside the U.S. or in another country.